THREE-DIMENSIONAL HISTOLOGICAL RECONSTRUCTION

A semi-automatic system for acquiring three-dimensional structural information about histological material is being developed. The system should be faster and more reliable than techniques that use serial sections, although resolution may be limited. In brief, an embedded tissue block will be fixed relative to a scanning electron microscope imaging system; the surface of the block will be imaged and the image stored, and successive slices will be removed by a built-in microtome. Handling and registration of thin sections will thus be eliminated. Human and computer pattern recognition will transform the resulting set of images into a three-dimensional reconstruction. The images of Hermissenda crassicornis obtained by this technique correlate well with TEM images of the same tissue.